Great Lakes NARCH 13 Gikendan Gegoo Endaso Giizhig

GLNARCH OVERALL
This application builds upon the strong partnerships between tribal organizations and academic institutions in the Indian Health Service Bemidji Area of Michigan (MI), Minnesota (MN) and Wisconsin (WI). The Great Lakes Native American Research Center for Health (GLNARCH) is based at the Great Lakes Inter-Tribal Council (GLITC) central office on the Lac du Flambeau reservation in northern WI. The primary academic partner is Medical College of Wisconsin (MCW). The overall theme of this GLNARCH application is based on the Ojibwe saying: gikendan gegoo endaso giizhig, which means “learn something every day”. To accomplish this, GLNARCH components will holistically support students, trainees, and researchers using methods tailored to the regional Great Lakes Native American traditions and contemporary context. Each proposed component will independently contribute to this theme: 1) the Administrative Core provides integrating support, 2) the Research Capacity Building component accelerates collaborative research infrastructure development amongst Tribal Colleges and Universities (TCUs), 3) The Student Career Enhancement I (SCEP I) encourages youth participation in higher education via experiential learning, and 4) The Student Career Enhancement II (SCEP II) supports Native American students already in higher education with mentoring and networking opportunities. The overall outcomes of this approach are improved: connectivity, self-efficacy, belonging, and research collaboration among our above-listed partners

Public health relevance
NARRATIVE: GLNARCH OVERALL This Great Lakes Native American Research Centers for Health (GLNARCH) is housed at the Great Lakes Inter-Tribal Council. This application aligns established partnerships to promote a synergistic education, training, and research within the Indian Health Service Bemidji Region with increased focus on including Tribal Colleges and Universities (TCUs). The Center is composed of an Administrative Core, Capacity Building project (NEHR), and two Career Enhancement projects (SCEP I and II).